Can Sensory Feedback Training Improve the Biomechanical and Metabolic Effects of Using Passive or Powered Lower Limb Prostheses During Walking for Veterans with Transtibial Amputations?

[Due to the functional impairments caused by a lower limb amputation, it is essential to determine the
benefits of rehabilitation strategies such as real-time visual feedback training. Such training could allow
Veterans with transtibial amputations (TTAs) to better utilize their prostheses and regain the greatest possible
level of function. It is not clear how much the prosthetic device (passive-elastic prosthetic foot versus battery-
powered ankle-foot prosthesis) and/or the user’s response to the prosthesis contribute to the biomechanical
and metabolic effects of using these prostheses during walking. Better use of a prosthesis due to targeted real-
time visual feedback training could enhance rehabilitation, improve function and reduce asymmetric
biomechanics, which in turn could reduce common comorbidities such as osteoarthritis, leg and back pain, and
indirectly, diabetes in Veterans with TTAs. The purpose of the proposed project is to systematically establish
the metabolic and biomechanical effects of targeted real-time visual feedback training of peak propulsive
ground reaction force (GRF) on the biomechanics, metabolic costs, and muscle activity of Veterans with TTAs
using their own passive-elastic prosthetic foot and a battery-powered ankle-foot prosthesis. The results of our
research could enhance the use of prosthetic technology to improve the rehabilitation and function of Veterans
with lower limb amputations.
Previous studies suggest that use of passive-elastic and/or powered ankle-foot prostheses may not
optimize the function of Veterans with TTAs during walking. Targeted, real-time visual feedback training of
peak propulsive ground reaction forces increased propulsion and improved walking function in older (>65
years) and post-stroke adults, who typically have impaired ankle power. To our knowledge, no research has
addressed how visual feedback of peak propulsive force affects the use of passive-elastic or powered ankle-
foot prostheses by people with TTAs. In the proposed research, we will determine the underlying metabolic
costs, biomechanics, stability, and muscle activity resulting from targeted real-time visual feedback training of
peak propulsive force to identify how Veterans with a TTA benefit from more effective use of a passive-elastic
prosthesis and/or a battery-powered ankle-foot prosthesis and to determine if the addition of mechanical power
provided by a battery-powered ankle-foot prosthesis can further enhance the function of Veterans with
unilateral TTAs during walking. 30 Veterans with unilateral TTAs will use their own passive-elastic prosthesis
both with and without visual feedback training during level-ground walking, while we measure their metabolic
costs and biomechanics. Then, they will use a powered ankle-foot prosthesis (emPOWER, BiONX, Ottobock)
both with and without visual feedback training during level-ground walking, while we measure their metabolic
costs and biomechanics. With each prosthesis, subjects will walk at 1.25 m/s on a dual-belt force-measuring
treadmill 1) with no visual feedback, and then with real-time visual feedback of: 2) peak propulsive force from
the “no feedback” condition, 3) +20% greater peak propulsive force, and 4) +40% greater peak propulsive
force. During these visual feedback trials, we will ask subjects to match the peak propulsive force displayed on
a computer screen with their affected leg. We will also ask subjects to: 5) match symmetric visual feedback of
the peak propulsive force from both legs. We will determine if Veterans with TTAs utilizing real-time visual
feedback training of peak propulsive force can improve metabolic costs, biomechanical symmetry, and
dynamic stability/balance, while using their own passive-elastic prosthesis or a powered ankle-foot prosthesis.
We will also establish if Veterans with TTAs can retain the metabolic and biomechanical benefits elicited by
real-time visual feedback training once that feedback is removed. Results from the proposed project will be
used to inform rehabilitation strategies and prosthetic design, which could ultimately improve health, maximize
function, and improve quality of life for Veterans with TTAs.]

Public health relevance
[Previous studies suggest that Veterans with a below the knee amputation using passive-elastic or powered prostheses have impaired physical function, which could increase the risk of osteoarthritis, leg/back pain, and diabetes/obesity. Utilization of rehabilitation strategies/techniques such as real-time visual feedback training could restore physical function, increase physical activity, and reduce injury risk. We will systematically determine the effects of using real-time visual feedback training of peak propulsive (push-off) force during walking while Veterans with below the knee amputations use a passive-elastic and battery-powered prosthesis. Similar to previous studies of non-amputee older (>65 years) and post-stroke adults, use of real-time visual feedback training of propulsive force will likely improve walking function in Veterans with amputations. Such training presents a promising rehabilitation strategy that could reduce comorbidities, while improving quality of life, comfort, and physical function, and advancing rehabilitation research and prosthetic development.]